Administrative and Career Core

PROJECT SUMMARY – Administrative Core
The Administrative Core (Admin-Core) has established an organizational structure that serves the mission of
the UC Davis Environmental Health Sciences Core Center (EHSC): to advance understanding of
environmentally-induced disease and disability and to develop interventions that reduce hazardous exposures
or lessen their effects on health. This Core supports each of the other Cores, the Advisory groups, and the
Working Groups; provides resources for all EHSC members to capitalize on emerging opportunities; and
enables Center Leaders to effectively guide the EHSC towards greater impact through its research, community
engagement, and translational efforts.
In fewer than 4 years, this Core provided administrative support to successfully integrate previously disparate
clusters of investigators working on exposure science, toxicology, disease mechanisms, epidemiology and
environmental justice into a cohesive group that collectively is pursuing a wide range of new collaborations and
generating cutting edge science. The Admin-Core was instrumental in the launch of a robust research
response to wildfires in California; recruitment of over a dozen investigators new to EHS through coordination
and campus-wide publicizing of the pilot project program; and integration of community stakeholders and their
concerns in our annual retreats and discussion of priorities. In the next funding period, the Admin-Core will
provide services in four areas: 1) Management of fiscal operations, documentation and evaluation of activities,
compliance, and progress, and scientific leadership for decision-making and priority-setting to govern the
overall direction of the Center, new research initiatives and translational projects. 2) Career development,
including a monthly critical review of Specific Aims for any environmental health-related grant application, an
EHS Scholar award, a course in program management and leadership, and structured mentoring for pilot
award recipients who are early stage investigators or established investigators new to EHS. 3) Coordination of
research infrastructure and translation: by promoting/supporting interdisciplinary collaborations, Working
Groups, cross-Core interactions, disaster research response, and engagement with other UCD Centers; and
by working in concert with the Community Engagement Core and community stakeholders on moving EHS
research into policy interventions and public health practices. 4) Communications: internally to all members
and to Center leaders of the Cores and Working Groups to enhance integration, participation and our sense of
purpose, and externally to amplify visibility of the EHSC, including to UCD Administrators, Advisory bodies,
funding agencies, other Core Centers, government and policy-makers, and to stakeholders and the broad
public through events, social media, traditional outlets, website, film, and others. The Admin-Core will continue
to grow the EHSC’s capacity to address pressing environmental health issues; accelerate translation of results
into policies and practices that improve public health; and work towards long-term sustainability.